Simultaneous analysis of cell-borne and soluble biomarkers by high throughput acoustic flow cytometry

Project Summary
Analysis of complex cellular processes in understanding disease, development of drugs, or testing
efficacy of therapies often requires dynamic measurements of both cellular markers and cellular
products. The ability to synchronously and rapidly conduct such measurements in complex cell-
containing samples using a single instrumental analysis will be useful and beneficial across
biotechnology. The goal of this project is to enable such multiplex analysis of T-cell activation using
immunophenotyping and quantitative monitoring of their secreted cytokines as an important model
system. High throughput measurement of samples of suspended cells is made possible using
BennuBio’s Velocyt® multi-stream acoustic flow cytometry system. The primary innovation of this
project is the implementation of negative acoustic contrast particles (NACPs) as a bead-based
immunoassay platform that significantly extends the analytical capabilities of the Velocyt® instrument
for simultaneous analysis of cell-associated and soluble biomarkers. In contrast to cells, which
migrate to, and are analyzed at, discreet positions within the Velocyt® flow stream,NACPs are
separated to distinct positions in the flow stream, allowing for easy discrimination between bead and
cells in a single sample. In this proof-of-concept Phase I research, we aim to conduct simultaneous
measurement of the T-cell activation marker CD25 in both the CD4 and CD8 population at the same
time that we measure secreted interferon-γ and tumor necrosis factor-α . While this demonstration will
be of significance to the development of pharmaceuticals for treatment of a range of immunological
and infectious diseases that involve T-cell activation, it will also provide a firm basis by which to
design and commercialize customizable NACP-based reagent kits to address a wide range of
disciplines across biotechnology.

Public health relevance
Project Narrative This project will establish the feasibility of developing a new bead-based reagent technology for use with BennuBio’s Velocyt® high throughput acoustic flow cytometry system. This technology will augment the Velocyt’s® rapid cell analysis capabilities to enable simultaneous quantitative measurement of cell-secreted biomarkers. Concurrent, multiplex analysis of cell-borne and secreted, soluble biomarkers will simplify the development of therapeutics targeting a wide range of diseases and enable important new capabilities across biotechnology.